Using simulation for teaching femoral arterial access: A multi centric collaborat

DESCRIPTION (provided by applicant): Femoral arterial access is performed in approximately 2 million patients every year as part of cardiac catheterization procedures. Vascular complications occur in approximately 3% of patients undergoing coronary intervention and are associated with significant morbidity and mortality. There is an increase in vascular complications that corresponds with the beginning of the academic cycle and trainees have more complications in their first few procedures than later when they are more experienced. Methods: To help improve patient safety we propose a three step process to use simulation to teach femoral arterial access. This involves the development of a valid simulation model that provides realistic training for obtaining femoral arterial access, a program to incorporate the simulation model in the education curricula of cardiology fellowships at four major training institutions and follow up collection of data to assess for change in complication rates across these institutions. In the final phase, this simulation model would be made available to all the cardiac catheterization laboratories in the state of Michigan for training of any member of the catheterization laboratory who might be involved in obtaining arterial access. The program leverages the ongoing collaborative network of interventional cardiologists unique to the Blue Cross Blue Shield of Michigan cardiovascular collaborative (BMC2). Impact: The introduction of simulation system to teach femoral arterial access across a number of hospitals connected in a learning network will ensure rapid dissemination and early reduction in procedural complications. PUBLIC HEALTH RELEVANCE: The goal of the proposal is to create a user friendly life like simulator for teaching femoral access. This simulator will be initially validated at four teaching hospitals and then introduced as a learning tool in all hospitals performing PCI in the state of Michigan.

Public health relevance
The goal of the proposal is to create a user friendly life like simulator for teaching femoral access. This simulator will be initially validated at four teaching hospitals and then introduced as a learning tool in all hospitals performing PCI in the state of Michigan.